2025 Modulation of Neural Circuits and Behavior Gordon Research Conference and Gordon Research Seminar

Project Summary
The 2025 GRC chairs are organizing a Gordon Research Conference (GRC) with an associated Gordon
Research Seminar (GRS) for young scientists on “Modulation of Neural Circuits and Behavior” from May 18-23,
2025, in Les Diablerets, Switzerland. Brains adjust information processing and optimize behaviors in response
to ever-changing environmental demands. This astonishing flexibility relies on neuromodulatory systems,
encompassing catecholamine and neuropeptide signaling. Neuromodulation facilitates dynamic and adaptive
neuronal processing both locally and brain-wide across various temporal scales. The modulation of brain
functions regulates basic survival behaviors such as sex, aggression, or parental care, and it is of crucial
importance for cognitive functions such as decision-making and learning. Deep insights into neuromodulation
are not only critical to understanding the neural basis of intelligence and behavior but also to understanding how
different mental states, motivations, salience, and other important phenomena are controlled. Moreover,
mechanistic insights into neuromodulatory mechanisms are key to understanding brain dysfunctions and
diseases, including depression, post-traumatic stress disorder, and many others. Although foundational
discoveries about neuromodulatory systems were made decades ago, new methods for in vivo imaging, neuronal
and neural circuit manipulation, quantification of behavior, and computational modeling are revisiting and
providing new insights into the role of neuromodulation in circuit dynamics and behaviors. The 2025 “Modulation
of Neural Circuits and Behavior” GRC/GRS will bring together scientists with diverse backgrounds to discuss
current concepts and exciting new results in this growing field. The meeting will cut across disciplines and model
organisms and focus on topics with a high potential to synergize. Rather than following traditional subdivisions
of the broad field of neuromodulation, the session topics will bridge between scientific communities and
disciplines. The organizing committee expects that the organized and informal discussions will generate new
insights and highlight promising directions for future progress.

Public health relevance
Project Narrative Animals constantly adjust their behaviors in response to predictable and unexpected changes in their external and internal environment, and these flexible behaviors are supported by the broad and complicated neuromodulation that remains poorly understood. Malfunction in neuromodulation could lead to various neurological and psychiatric disorders. The goal of this interdisciplinary conference is to bring a diverse group of scientists together to showcase their latest findings on neuromodulation, share insights and research strategies, and establish discussion and collaboration across fields.